Impact of Parental Long Term Thermoneutral Ambient Temperature on Offspring Health

The first objective is to determine how multi-generational ambient temperature, specifically thermoneutral temperature, modulates the metabolic health of parents and subsequently programs the metabolic health of the next generation. The hypothesis is that prolonged exposure to thermoneutral ambient temperature will lead to dysfunctional adipose tissue and impair the metabolic health of parents, resulting in an increased predisposition to obesity in the offspring. Preliminary data from pilot studies have already shown significant
changes in the weight gain ability and adipose tissue morphology of offspring born to thermoneutral temperature housed parents to that offspring born to cold temperature housed parents. The second objective aims to identify the impact of parental housing temperature on the inflammatory profile of offspring adipose tissue, with a focus on understanding the role of parental temperature exposure in
modulating adipose tissue inflammation programming. It is hypothesized that the inflammatory response in offspring adipose tissue will differ between adipocytes and the stromal vascular fraction based on parental housing temperature. Preliminary data showed that changes in parental ambient temperature resulted in changes in the expression of genes involved in immune response in offspring adipose tissue. By pursuing these specific aims, we aim to gain a better understanding of how ambient temperature modulation during
parental stages influences the metabolic programming of offspring. The findings have the potential to uncover new mechanisms and interventions to reduce the risk of obesity and associated health complications, ultimately contributing to improved public health outcomes in high-income countries.